Understanding the origin of parthenogenesis

Project Summary
Parthenogenesis (i.e., reproduction without mating) has evolved from sexual reproduction in nearly all major
eukaryotic groups. In parthenogenesis, chromosomally unreduced (e.g., diploid) gametes result from modified
forms of meiosis. Understanding the genetic mechanisms underlying the modification of meiosis in
parthenogenetic lineages is of significant public health interest because meiosis is central to sexual reproduction.
Using parthenogenesis to understand the genetic regulation of meiosis is also a highly innovative approach, with
its natural history perspective most likely yielding novel knowledge about meiosis. Using a combination of
evolutionary and functional genomic approaches, this project examines the genetic bases of cyclical and obligate
parthenogenesis in the freshwater microcrustacean Daphnia. Daphnia is well known for its cyclical
parthenogenesis (CP) life cycle, i.e., propagating asexually under favorable environmental conditions and
switching to sexual reproduction in response to stressful environment. Interestingly, some populations of the
species D. pulex (backcrosses of two parental CP species D. pulex and D. pulicaria) reproduce by obligate
parthenogenesis (OP) because they lost the capability to engage in sex. My lab has two long-term goals. First,
considering that environmental conditions can trigger CP Daphnia to switch between parthenogenetic and sexual
reproduction, environment-mediated gene expression changes most likely play the role of master regulator for
reproductive mode. Our recent transcriptomic analyses revealed the many paralogous genes in the Daphnia
genome show divergent expression associated with reproduction mode. For example, one paralog is upregulated
in parthenogenesis, whereas the other paralog is upregulated in sexual reproduction. These paralogous contain
multiple transmembrane receptors, neurotransmitter receptors, and transcription factors. We therefore
hypothesize that these paralogs contain the master regulator of cyclical parthenogenesis. To identify the master
regulator(s), we plan to use forward genetic screening to identify mutants that are not able to switch reproductive
modes and identify the causal genes using functional analysis such as CRISPR gene editing. We will also directly
perform gene knockout experiments to examine the functions of the divergently expressed paralogs in relation
to reproduction in CP Daphnia. Second, concerning the origin of OP, we hypothesize that incompatible genetic
elements between the two parental species CP D. pulex and CP D. pulicaria are responsible for the loss of
sexual reproduction. To identify the causal incompatible elements, our lab will perform large-scale association
mapping on newly discovered D. pulex crosses (between CP D. pulex isolate carrying D. pulicaria introgression)
that produce both OP and CP F1s. The identified candidates will undergo functional genomics analysis (e.g.,
CRISPR gene knock-out), with the goal of re-creating OP animals by introducing OP-causal elements to CP
Daphnia using gene editing. Lastly, we will examine whether the identified elements are present in natural OP
isolates to understand whether multiple genetic mechanisms underlie the origin of OP.

Public health relevance
Project Narrative PI – Sen Xu Investigating the genetic basis of parthenogenesis (i.e., reproduction without sex) will provide insight into the genetic regulation of meiosis that plays a central role in sexual reproduction. Using cutting-edge genomic technologies, this project examines the evolutionary and genetic mechanisms responsible for the origin of parthenogenesis in the freshwater microcrustacean Daphnia. The outcome of this project will lead to novel understanding of animal reproduction.